Evaluating the Feasibility of Central Executive Training for Children with ADHD- Administrative Supplement

DESCRIPTION (provided by applicant): Consistent with NIMH Strategic Objective #3, the proposed project seeks to translate clinical neuropsychological findings regarding underlying impairments in children with ADHD into new and better interventions that incorporate the diverse needs and circumstances of these children (NIMH, 2008). Specifically, the goal of the core study is to develop a central executive training (CET) intervention for children with attention-deficit/hyperactivity disorder (ADHD) and examine its feasibility, acceptability, engagement, and usability. This will involve early developmental work on software and treatment manuals followed by evaluation of the feasibility of enrolling, retaining, and treating ADHD children with CET. An evidence-informed intervention targeting central executive functioning in children with ADHD has the potential to result in clinically significant improvements in ADHD symptoms relative to extant behavioral treatments and capacity-based (short-term memory) training interventions. The long-term goal is to develop an efficacious and acceptable CET intervention with the potential for generalized improvements in, or normalization of, ADHD-related impairments in peer, family, and academic functioning.

Public health relevance
PUBLIC HEALTH RELEVANCE: Consistent with NIMH Strategic Objective #3, the proposed project seeks to translate clinical neuropsychological findings into "new and better interventions that incorporate the diverse needs and circumstances" of children with ADHD. Toward this end, the goal of the current project is to develop and assess the feasibility, acceptability, engagement, and usability of a novel, central executive (CE) working memory training intervention. Drawing on advances in cognitive and clinical science, behavioral methods, and serious games research, an evidence-informed intervention targeting CE functioning in children with ADHD has the potential to result in clinically significant improvements in ADHD behavioral, interpersonal, and functional impairments relative to extant behavioral treatments and capacity-based (short-term memory) training interventions.